Diabetes Research and Engagement through Advanced Multilevel Science Center for Diabetes Translational Research (DREAMS-CDTR)

Diabetes mellitus is a significant health burden in the United States; the prevalence of Type 2 diabetes (T2DM) is growing rapidly and rates of diabetes complications are on the rise. Led by diabetes translational researchers from the Kaiser Permanente Northern California Division of Research, Stanford University, University of California San Francisco, University of California Davis, and University of California Merced, the Diabetes Research and Engagement through Advanced Multilevel Science Center for Diabetes Translation Research (DREAMS-CDTR) seeks to catalyze the development and implementation of innovative, high-impact, and sustainable interventions to improve diabetes outcomes across all U.S. populations. DREAMS- CDTR seeks to inform real-world practices and policies in care delivery, public health and community settings as follows: Specific Aim 1: To maintain, grow and deepen a robust cross- disciplinary network that supports diabetes translational research within and across multiple institutions in northern California; Specific Aim 2: To maintain and strengthen two Translational Research Cores in Health Engagement and Action Translation and Methods and Data Integration, as well as a Diabetes Policy Research Resource Core. Specific Aim 3: To maintain and enhance Pilot and Feasibility and Enrichment programs to support and fund preliminary research essential for planning future diabetes translational R01s, R21s, and K-awards by Early-Stage Investigators.
CDTR Overall Center

Public health relevance
NA) The National DPR Core will draw upon the research expertise of its faculty members to advance the translation of health policy research into action to improve diabetes prevention and treatment outcomes. The National DPR Core will be dedicated to expanding core services to investigators and others outside of the DREAMS-CDTR, offering collaborations between epidemiologists, economists, and health service researchers; and facilitating linkages to community health plans, public health departments and social service agencies for diabetes researchers. Modified Specific Aims Section (NOTE THAT NIH ALREADY MODIFIED THESE) Enter the text here that is the new specific aims information for your application. The Specific Aims of the DPR core are as follows: SA1: Provide on-demand consultations with a focus on augmenting and enhancing access to common databases, an opensource code library of new methods, and shared tutorials to enhance the efficiency, productivity, and effectiveness of diabetes translation research; SA2: Deliver monthly webinars from CDTR faculty and invited guests, that are topical and highlight practical approaches to considering and implementing new methodological developments to support policy research on population health SA3: Advise on grant-writing on the five key areas of diabetes policy research to enhance scientific progress and improve the uptake of research aimed at evaluating policies that intend to improve the prevention and treatment of diabetes mellitus. Modified Public Health Relevance Section NA) Diabetes mellitus is a significant health burden in the U.S. Focusing on the northern California and its Central Valley region, the DREAMS-CDTR will conduct clinical research and interventions designed to inform practice and policy change at the health system, community and policy levels. The DREAMS-CDTR activities include: an Administrative Core, Pilot and Feasibility Program, Enrichment Program, and three coordinated research cores - Health Engagement & Action Translational (HEAT) core, Methods and Data Integration (MDI) translational core, and National Diabetes Policy Research Resource core. The Enrichment Program will provide structure to the professional development and networking opportunities across the DREAMS-CDTR and the CDTR national network. Modified Specific Aims Section (NOTE THIS WAS ALREADY MODIFIED BY NIH) Enter the text here that is the new specific aims information for your application. The DREAMS-CDTR Enrichment Program has three Specific Aims (SAs): SA1: To provide dynamic monthly seminars conducted by DREAMS-CDTR Core faculty that present cutting-edge diabetes translational research and methods, bridge gaps across institutions and disciplines, and highlight the contributions of early-stage investigators. SA2: To encourage and facilitate participation by all Center faculty and mentees, as well as clinical and community stakeholders in a wide range of educational programs sponsored by our Center sites. SA3: To provide professional development and networking opportunities to junior faculty applying for translational research funding in diabetes and diabetes prevention. Modified Public Health Relevance Section NA) The Health Engagement & Action Translational (HEAT) Research Core will employ a multi-level systems approach to designing action-oriented, rigorous community engagement, observational and interventional research to promote improved diabetes outcomes in the greater San Francisco Bay Area and the Central Valley. This goal will be accomplished by 1.) Maintaining and deepening a vibrant and collaborative cross- disciplinary research environment, 2.) Supporting junior investigators, 3.) Disseminating findings among the scientific community and with key stakeholders, including the communities most affected by diabetes, and 4.) Providing timely, authoritative and tailored consultation to a range of stakeholders, including investigators, local health system leaders, community-based organizations, and regional public health, social service and social policy entities. Modified Specific Aims Section (NOTE THIS WAS ALREADY MODIFIED BY NIH) Enter the text here that is the new specific aims information for your application. The Specific Aims of the Health Engagement & Action Translation (HEAT) Core are to: SA1: Create a vibrant and collaborative cross-disciplinary research environment across the sites within our DREAMS-CDTR, and with the other NIDDK-funded CDTRs. This will also require strengthening ties with community-based organizations, regional public health entities and policy entities whose missions have overlap with the goal of promoting diabetes prevention and improved diabetes care. SA2: Support junior investigators within our DREAMS-CDTR to propose, develop and conduct diabetes translational research projects focused on multi-level, action-oriented translational research by engaging them in scientific discourse, networking opportunities, and opportunities for support and guidance through the Pilot and Feasibility Core and Enrichment Program SA3: Disseminate knowledge of the cross-disciplinary frameworks, methods and findings of the DREAMS-CDTR’s diabetes translational research and associated health and health economic implications to our members and the medical community through presentations, publications, and social media. SA4: Provide timely, authoritative and tailored consultation to a range of stakeholders, including investigators, local health system leaders, community-based organizations, and regional public health and policy entities. Modified Public Health Relevance Section NA) Methods and Data Integration (MDI) Core Over the last decade, there have been substantive advances in analytic research methods and the introduction of novel sources and methods of data collection for translational research; these offer tremendous potential for improving the prevention and management of type 2 diabetes. The MDI Core will promote technological advances in data and research methods that can be applied to support interventions in the T2-T4 translational research continuum ranging from ‘bench-to-bedside’ research, clinical care and health services research, community-based intervention research, implementation sciences research, comparative effectiveness analysis, all the way to agent-based simulation models that influence policy, systems and environments. We will support a research environment that disseminates new statistical and analytic approaches, such as hierarchical models, causal modeling, machine learning and artificial intelligence techniques, and technological advances in data sources such as lab-based biomarkers, remotely collected health data, and population health data. Modified Specific Aims Section (NOTE THIS WAS ALREADY MODIFIED BY NIH) Enter the text here that is the new specific aims information for your application. The Specific Aims of the MDI Core are to focus on integrating multilevel data and utilizing novel methods, including: SA1: Mentor junior investigators within our DREAMS-CDTR research center to propose, develop, and conduct diabetes translational research projects with multilevel data integration, using advanced statistical and analytic methods, to improve diabetes prevention and care. SA2: Provide evidence-based consulting to CDTR, health system, and community partners regarding analytic methods and data needed to assess innovations in diabetes care and prevention. SA3: Disseminate knowledge of novel research methods and data resources facilitating multilevel diabetes translational research and analysis of its impact on diabetes care and prevention to research sites within our CDTR, among all NIDDK-funded CDTRs and the broader research and public health community. Modified Public Health Relevance Section NA Enter the text here that is the new abstract information for your application. The DREAMS-CDTR maintains a robust Pilot and Feasibility Program that supports studies that lead to future R-level and K-level grants in diabetes translational research. This Program aims to support two Pilot and Feasibility studies in each year of the CDTR renewal, conduct peer review of Pilot and Feasibility award applications on an annual basis, and leverage the Pilot and Feasibility awards as a mechanism to support junior investigators in developing robust careers in translational research in diabetes and diabetes prevention. To ensure the continued success of the P and F program, The DREAMS-CDTR will work with the External Advisory Committee to evaluate progress with stated goals, as well as gather feedback from P and F awardees regarding specific activities on an ongoing basis. Modified Specific Aims Section (NOTE THIS WAS ALREADY MODIFIED BY NIH) Enter the text here that is the new specific aims information for your application. The Pilot and Feasibility Program has three Specific Aims: SA1: To support two Pilot and Feasibility studies in each year of the DREAMS-CDTR renewal. SA2: To conduct peer review of Pilot and Feasibility award applications on an annual basis, using the following criteria: overall impact; relevance to diabetes translational research; the promise for leading to an R-level grant submission; relevance to the Center’s Translational Research Cores; and support from the health care delivery system or community in which they are initiated. SA3: To leverage the Pilot and Feasibility awards as a mechanism to advance the career development of junior investigators in diabetes translational research. Modified Public Health Relevance Section NA)